Administrative Core

Project summary
The Asia-Pacific ICEMR relies on a highly effective administrative center, based at the Walter and Eliza Hall
Institute (WEHI) in Melbourne, Australia to promote and maintain the between field, laboratory research and data
management centers. Our extensive experience from previous ICEMR programs has resulted in a very efficient
and well-supported admin management structure embedded within Prof Mueller’s laboratory at WEHI and
leverages the strong scientific support network across our research grants, finance and legal departments.
Our project, with intersecting activities proposed between the Projects and Cores, is integrative by design. The
two Projects, Epidemiology and Transmission are supported by a network of collaborations across institutions
and strongly supported by the two scientific Cores: Data Management, Statistical support and Modelling; and
Diagnostics and Surveillance.
The admin core exists to facilitate coordination of all project activities, data and scientific resource sharing,
contractual and ethical documentation, and all financial management across every aspect of the project. We will
be the contact point for all communications with NIH and other ICEMR teams and strive to enable interactive
collaboration with the other ICEMRs. We are responsible for all reporting and will ensure timely communications
with NIH officials and SAG members.

Public health relevance
Project narrative There are several common barriers to malaria elimination that countries in the Asia-Pacific region are facing – increasingly heterogenous transmission driven by asymptomatic infections, environmental change affecting malaria ecology, emerging drug and insecticide resistance, the resilience of P. vivax malaria and resource constraints. We will address these barriers to elimination through a coordinated program of epidemiological and transmission studies that combines epidemiological, clinical and entomological investigations, innovative molecular and serological diagnostics with advanced mathematical transmission modelling across 5 field sites in Cambodia and Papua New Guinea that span the transmission gradient from very low to high. By developing better surveillance approaches that allow better targeting of intervention, improving P. vivax case management, monitoring the changing vector distribution and behavior and tracking the spread of drug and insecticide resistance, evidence from our research will inform program action to accelerate towards zero malaria in the region.